Genetic Modifiers and Diagnostics for Bone Health in Cystic Fibrosis

PROJECT SUMMARY/ABSTRACT
Osteoporotic fractures increase morbidity and mortality in people with CF; vertebral fractures are the most
common osteoporotic fracture in people with CF. Diagnosing CF osteoporosis is hindered by two critical gaps:
the current standard of care (use of dual energy X-ray absorptiometry, DXA) has poor sensitivity for fracture in
people with CF and fracture risk strata have not been defined in this population. Beyond DXA, other genetic and
imaging data are used to predict fracture risk in people without CF. Genetics explains 50% of variation in vertebral
fractures; genetic modifiers alter non-CF osteoporosis risk, but genetic modifiers specific to CF osteoporosis
have not yet been identified. Volumetric bone density (vBMD) by CT is superior to bone density by DXA in
predicting vertebral fracture in non-CF populations, but has not yet been investigated in people with CF.
Identification of genetic modifiers associated with CF osteoporosis and building prediction models for
osteoporosis using quantitative measures of bone strength derived from CT imaging can address this critical
knowledge gap in CF osteoporosis. To test the hypothesis that genetic modifiers and imaging biomarkers will
identify people with CF at highest risk for vertebral fracture, I will conduct three aims: 1) discover genetic
modifiers of CF osteoporosis through candidate and genome wide association study approaches, 2) examine
the relationship of volumetric bone density and vertebral fracture in people with CF, and 3) explore the
association of genetic modifiers, volumetric bone density and vertebral fracture. Data generated will enable
identification of people with CF at highest risk for vertebral fracture and be preliminary data for future R01
applications. This proposal will support the training of Dr. Malinda Wu, a pediatric endocrinologist, who is
dedicated to an academic career studying osteoporosis, using CF as the model. During the K23 award period,
she will acquire requisite skills in clinical and translational investigation through formal coursework and
workshops, attendance of conferences and seminars, personalized mentoring and hands-on research
experience. Dr. Wu will be mentored by Dr. Scott Blackman, expert in genetic modifiers of CF complications,
and Dr. Janet Crane, expert in bone biology. She has assembled a diverse team of experts with the skills,
resources, and expertise to guide her to successfully complete this project. In summary, the research and training
plan proposed in this K23 application will broaden our understanding of CF osteoporosis which has implications
for non-CF osteoporosis and provide the necessary training and investigational niche for Dr. Wu to develop a
successful, independent career in research.

Public health relevance
PROJECT NARRATIVE Osteoporosis afflicts people with cystic fibrosis (CF) at younger ages and higher rates than the general population, increasing morbidity and mortality in people with CF. This proposal will identify genetic, clinical and imaging data to predict fracture risk in people with CF to facilitate earlier identification of people with CF at higher risk for osteoporosis. Using CF as a model to study osteoporosis, these data will reveal osteoporosis mechanisms, suggest therapeutic targets, and refine osteoporosis screening algorithms.